The Role of Hearing Loss in Health Care Outcomes.

ABSTRACT
This is an application for a K23 Mentored Patient-Oriented Career Development Award for Dr. Nicholas Reed
who recently joined the faculty of the Department of Otolaryngology-Head & Neck Surgery at the Johns
Hopkins University School of Medicine as an Assistant Professor. The goal of the proposed project is to
provide the candidate with the advanced training and skills to launch an independent research program
examining hearing loss and health care outcomes among older adults. To facilitate this goal, the candidate has
assembled a multidisciplinary mentorship and collaboration team with expertise that spans epidemiology,
biostatistics, implementation science, gerontology, health systems and policy, nursing, delirium, and hearing
loss. He proposes a comprehensive training plan that consists of coursework, observation, practical training,
engagement in seminars, workshops, and working groups, and constructive research meetings across clinical
and academic centers at Johns Hopkins University, Harvard University, Indiana University, University
California, San Francisco, and University of Pittsburgh. The specific training and development goals of this
Award include: (1) instruction in trial design, epidemiology, and biostatistics methodology to apply in the
proposed research, (2) training in aging research and gerontologic care considerations with specific emphasis
on understanding conceptual models, measurement of, and interventions for delirium, (3) guidance in
implementation science methodology, process evaluation, and outcomes research as they apply to health
systems initiatives to improve quality of care among older adults, (4) continued training in the responsible
conduct of research with emphasis on considerations for clinical practice-based research, and (5) development
and submission of an R01 grant application that builds upon the methodologic foundation, preliminary
evidence, publications, and collaborations from this Career Development Award. The proposed research of this
Career Development Award addresses the overlooked influence of hearing loss on health care outcomes and
seeks to refine methods to address hearing loss in the health care system. The specific goals are to (1)
investigate the association between hearing loss, communication impairment, and hearing aid use with health
care outcomes such as 30-day readmission, length of stay, and hospitalization in older adults, (2) characterize
incidence of delirium among hospitalized older adults with and without hearing loss, and (3) refine and assess
the feasibility and acceptability of implementing a comprehensive hearing loss screening and intervention
program to improve care outcomes in the inpatient setting. At the conclusion of this Career Development
Award, the candidate will have the skills, expertise, and preliminary evidence to be competitive for independent
research funding and design and execute translational research addressing hearing loss throughout the health
care system that could shape patient-care for the millions of older adults with hearing loss.

Public health relevance
Project Narrative The role of hearing loss in health care outcomes such as delirium and health care utilization, possibly mediated via poor patient-provider communication and sensory deprivation pathways, is poorly understood. This study characterizes these associations in epidemiologic datasets and clinical samples and explores a low-cost, low- risk sustainable solution to address hearing loss in the inpatient setting. This Award lays the groundwork for large clinical trials that investigate systematically addressing hearing loss to improve health care outcomes and potential translation of research to improve patient-care for the millions of older adults with hearing loss.